Clinical Core

Mount Sinai ADRC (Sano): Clinical Core (Core B) – Research Summary
The Clinical Core provides expertise in the clinical and biological characterization of individuals with cognitive
loss and dementia and the ability to identify non-impaired older individuals. This expertise is utilized to recruit
and maintain a cohort of participants of varying ages, clinical presentations, educational attainment, races and
ethnicities. This well-characterized cohort supports a broad array of dementia and cognitive research
conducted within the ISMMS, the Mount Sinai Health System (MSHS,) and national initiatives such as the
National Alzheimer's Coordinating Center (NACC), the Genome Wide Alzheimer's Study (GWAS), Alzheimer's
Disease Cooperative Studies (ADCS), and the Alzheimer's Disease Neuroimaging Initiative (ADNI). The role of
the core is to develop and implement clinical procedures and collect biomarkers for the high standard
characterization of elders spanning the spectrum of normal, prodromal, and various stages of affected subjects
into “research-ready” cohorts. The Clinical Core provides subjects, tissue, and data for studies as well as
clinical research expertise related to clinical manifestations of disease, disease course, treatment responses,
and recruitment feasibility to help guide the design and implementation of studies within the Center and broadly
within the MSHS. Within the Center, the Clinical Core provides the essentials for research: the subjects and
their clinical characterization to participate in the Biomarker and Genetics Cores; the clinical characterization of
brain donations and other specimens disseminated to the Neuropathology Core; clinical and educational
expertise to interact with the projects and trainees of the ORE and REC cores. The Core innovates in the
development of assessment tools; application of assessments to new populations; adaptation of new imaging
technologies into the clinical `real world'; and clinical trials of novel, under-studied or repurposed compounds.
The Core has a rich and successful history of outreach to groups underrepresented in dementia research and
provisions to continue this are built into this application. The Core is active in training young investigators and
supporting investigators from other fields who wish to study cognition in their clinical populations.